EFFECT OF LOW POTASSIUM DIET ON BLOOD PRESSURE, SYMPATHETIC NERVOUS SYSTEM

This project investigated whether the hypertensive effects of potassium deficiency, and the hypotensive effects of potassium replacement are mediated through the sympathetic nervous system.